A web-based platform for robust single-cell analysis, bulk data deconvolution and system-level analysis

PROJECT SUMMARY
Together with the ability to measure genome-wide expression of millions of individual cells, single-cell
technologies have also brought the challenge of translating such data into a better understanding of the
underlying biological phenomena. Existing computational methods and software for single-cell data analysis
have critical limitations related to scalability, accuracy, usability, and interpretation capabilities. The main goal of
this project is to pioneer a new platform for the analysis of single-cell data that is capable of: i) accurately
identifying cell types and their composition in complex tissues, ii) inferring cell developmental stages and pseudo-
time trajectories, and iii) identifying cell-type-specific pathways and putative mechanisms in a phenotype
comparison. The proposed platform will also be able to deconvolve bulk expression data to identify the cell type
composition of each bulk sample. The significance of the proposed work lies in its potential to provide new
methodologies for single-cell data analysis that far exceed the performance of current state-of-the-art techniques.
The accurate deconvolution will also allow researchers to extract more information from the vast repositories of
existing bulk data, including GDC/TCGA, NCBI SRA, GEO, and ArrayExpress, which are currently containing
data from bulk experiments that collectively cost over a billion dollars. The hypothesis driving this work is that
single-cell data analysis and cellular deconvolution of bulk data can greatly benefit from: i) the systems-level
knowledge that holds key characteristics for cellular developments, and ii) the valuable information available in
validated cell types and reference single-cell datasets available in single-cell atlases. Indeed, our preliminary
work shows that single-cell data analysis and cellular deconvolution can achieve an outstanding accuracy of
approximately 90—100% if we properly utilize reference single-cell datasets and pathway knowledge. The
proposed platform will be extensively validated by comparing its capabilities against the state-of-the-art software
in both single-cell data analysis (cell type identification, developmental states and time-trajectory inference,
systems-level analysis) and cellular deconvolution of bulk expression data. This will be done using both 663
datasets representing 279 cell types and 116 human organ parts (including bulk data, single-cell data, and
matched cell flow cytometry). The pathway analysis and mechanisms inference capabilities will be further
validated using real knock-out datasets (in which the true cause of the phenotype is known). The company,
Advaita, has a strong IP portfolio, an experienced team, and a proven track record in this area, having developed
and commercialized similar analysis platforms. Advaita's existing products are currently used by top principal
investigators, core facilities, and pharmaceutical companies around the world.

Public health relevance
PROJECT NARRATIVE Single-cell technologies are revolutionizing the progress of biomedical research because they allow researchers to monitor the biological systems at the single-cell resolution. This project will develop a complete analysis pipeline and web-based platform able to accurately identify cell type composition from both single-cell and bulk data, infer the developmental stages and trajectories of cells, and perform cell-type-specific, systems-level analysis. This platform is expected to have a major impact in many areas where single-cell technologies are currently used, including diagnostics, drug discovery, immunology, neurobiology, and cancer research.